Dissecting cell type-specific genetic programming of islet (dys)function in type 2 diabetes

PROJECT SUMMARY
Type 2 diabetes (T2D) is a complex genetic disease that occurs when pancreatic islets cannot secrete sufficient
insulin to overcome peripheral tissue insulin resistance. Genome-wide association studies (GWAS) have
identified DNA sequence variants associated with T2D (T2D SNVs) in >600 regions of the human genome. T2D
SNVs are enriched in islet cis-regulatory elements (CREs), implicating them as putative causal and functional
variants that contribute to T2D by altering islet transcriptional regulation and function. Focused variant-to-function
efforts are critical to understand the biological significance of these observations and identify novel therapeutic
targets in T2D. In recent work, we nominated 145 T2D SNVs as high-confidence functional variants that
significantly alter in vivo islet cis-regulatory element (CRE) chromatin accessibility (islet caQTL), but only a subset
of these variants has been linked by us or others to their candidate target genes. Based on published and
preliminary data, we hypothesize that these T2D SNVs alter cell type-specific (e.g., alpha, beta, and/or delta)
CRE use, activity, and target gene expression to contribute to islet (dys)function in T2D risk and progression. In
Aim 1, we will define how each of these T2D SNVs alters islet cell type-specific CRE use via chromatin
accessibility quantitative trait locus (caQTL) analysis of single nucleus ATAC-seq profiles from an 80-donor islet
cohort and CRE activity using massively parallel reporter assays (MPRA) in human islets. In Aim 2, we will
determine the target genes of our nominated T2D-overlapping CREs with cell type-specific resolution using
innovative and complementary computational (chromatin co-accessibility), genomic (CRISPR-QTL), and genetic
(expression QTL) approaches in primary human islets. In Aim 3, we will assess how T2D-associated changes in
islet cell type-specific target gene expression and composition affect islet (dys)function using both CRISPR/Cas9
and conventional knock-down and overexpression approaches to engineer human pseudoislets. This study will
significantly advance our understanding of the islet cell type-specific determinants of T2D risk and
pathophysiology. With complementary genetic, computational, and cell engineering approaches, we will identify
and validate T2D target genes as high-priority therapeutic candidates for detailed mechanistic studies, preclinical
models, and drug screening. Importantly, the development of ad hoc genomic tools to modulate and monitor cell
type-specific gene regulation and output in primary human islets will enhance cell-type-oriented studies in
primary and stem cell-derived human islets for disease modeling. Together, the novel tools and knowledge will
catalyze progress in T2D risk assessment, prevention, and treatment.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) is a complex genetic disorder associated with a substantial health burden that poses significant strain on the U.S. healthcare system. We have identified DNA sequence changes that we hypothesize alter cell type-specific gene regulatory programs in pancreatic islets—community of cells crucial to maintain blood sugar levels. In this project, we will use innovative genetic, genomic, and cellular engineering approaches to test this hypothesis and determine the perturbed genes and cell type-specific programs that contribute to T2D genetic risk and progression.